4/4: The INTEGRATE Study: Evaluating INTEGRATEd care to Improve Biopsychosocial Outcomes of Early Liver Transplant for Alcohol-Associated Liver Disease

Alcohol-associated liver disease (ALD), which includes alcohol-associated
cirrhosis (AAC) and alcohol-associated hepatitis (AH), is now the leading
indication for liver transplant (LT) in the US. Early LT (eLT), defined as LT
evaluation with <6 months of alcohol abstinence, is associated with acceptable
outcomes for AH in retrospective studies. However, prospective, multi-center
data including biopsychosocial factors on eLT for all advanced ALD patients is
lacking. It is known that alcohol cessation is the most important factor influencing
survival in ALD, and integrated alcohol use disorder (AUD)/ALD care is critical to
help patients achieve abstinence, yet the degree of care integration and how this
influences post-LT outcomes has not been systematically studied. Knowledge
gaps in eLT for ALD include: a) limited data on who gets referred for eLT and
referral barriers; b) lack of standardized biopsychosocial measures and
outcomes; and c) minimal stakeholder involvement beyond LT providers. There
is an urgent need to (1) define factors influencing eLT referral, (2) develop risk
prediction models of key patient-centered outcomes, (3) incorporate validated
biopsychosocial measures into models, and (4) evaluate the impact of integrated
care on outcomes following eLT. For example, The INTEGRATE collaborative,
comprised of multidisciplinary clinicians and researchers from the University of
Texas Southwestern Medical Center, University of Michigan, University of Miami,
and Columbia University-Weill Cornell Medicine, is ideally positioned to address
these urgent research needs. Collectively, we have developed a distinctive
investigator team with clinical and methodological expertise in ALD, AUD, LT,
behavioral research, risk modeling, data harmonization, causal inference, and
mixed-methods research, and a documented track record of NIH funding in LT
access, organ allocation, LT outcomes, and NIAAA funding in ALD/AUD. Our
large volume transplant centers with established protocols for eLT for ALD will
facilitate the following aims: 1) characterize and develop risk prediction models
for transplant-free survival among those with limited access to LT to define those
in greatest need of eLT referral and listing; 2) evaluate barriers and facilitators to
referral for eLT in ALD; 3) apply causal inference approaches to observational
data to evaluate biopsychosocial factors and develop risk models predictive of
outcomes at key timepoints in eLT for ALD; 4) define stakeholder perceptions
and preferences for selection and outcomes in eLT for ALD; and 5) evaluate how
integrated care processes influence outcomes in eLT for ALD. At the conclusion
of this work, we will have collaboratively: (1) defined factors for referral and
waitlisting for eLT in ALD (selection), (2) identified which biopsychosocial factors
are causally related and predictive of outcomes most important to stakeholders
(outcomes) and (3) determined how integrated care influences stakeholder-relevant
outcomes in eLT for ALD (management).

Public health relevance
Early liver transplantation (eLT), defined as LT evaluation with <6 months of alcohol abstinence, is associated with acceptable outcomes for patients with severe alcohol-associated liver disease (ALD) in retrospective studies. However, prospective, multi-center data including biopsychosocial factors on eLT for all patients with ALD are lacking. The INTEGRATE collaborative is a highly skilled investigative team that seeks to: 1) define factors influencing referral and waitlisting for eLT in ALD (selection); 2) identify which biopsychosocial factors are causally related and predictive of outcomes most important to stakeholders (outcomes); and 3) determine how integrated care among the healthcare team influences stakeholder-relevant outcomes in eLT for ALD (management).